Economic precarity, costs, and continuity of mental health care

PROJECT SUMMARY/ABSTRACT
Candidate: Catherine Ettman, PhD, is an early career mental health services researcher. Her long-term career
objective is to become an independent investigator and national expert on the role of different assets in
shaping mental health and mental health services utilization towards the end of reducing inequities.
Research Context: Depression is common, costly, and its burden is felt unequally. Treatment for depression
can be effective but is hampered by interruptions in care, such as appointment non-adherence, or no-show.
Reducing appointment no-show is a feasible and cost-efficient way to improve patient care and outcomes.
Specific Aims: 1) To test whether higher out-of-pocket healthcare costs increase psychiatric appointment no-
show; 2) To estimate the causal effect of clinical operations features (such as telehealth and appointment
reminders) on no-show and whether the effect varies across patients with access to different financial assets;
3) To identify the financial and other factors that most strongly predict psychiatric appointment no-show.
Research Plan: Using electronic health records (EHR) in a cohort of 23,420 patients with depression from the
Johns Hopkins Medicine Precision Medicine Center of Excellence on Mood Disorders, Dr. Ettman will
comprehensively examine the effect of financial and clinical operations features on psychiatric no-show in
patients with depression to inform intervention. In Aim 1, Dr. Ettman will use an instrumental variables
approach to estimate the effect of higher out-of-pocket costs on subsequent appointment no-show, leveraging
variation in facility fees, external to the patient and induced by Maryland state policy, as an instrument. In Aim
2, Dr. Ettman will use contemporary matching approaches such as full propensity score matching and doubly
robust methods to estimate the causal effect of clinical operations features (such as telehealth and
appointment reminders) on psychiatric appointment no-show and she will assess if the effect varies across
patients with access to different financial assets. In Aim 3, Dr. Ettman will use modern prediction models
including random forest and Lasso to determine which financial and other factors predict psychiatric no-show.
Career Development Plan: Dr. Ettman will develop expertise in 1) causal design, including instrumental
variable analysis and contemporary matching approaches; 2) health informatics, specifically advanced
prediction models; and 3) ethical and practical health system clinical operations. Dr. Ettman’s training will be
supported by close mentorship, advanced didactic coursework, and career development activities.
Research Goals: This proposal builds on Dr. Ettman’s track record of successful publication and project
management, a highly involved primary mentor and expert mentorship team, and strong institutional support,
while providing protected time for training. Together, this body of work will identify implementable policy
recommendations that improve population mental health.

Public health relevance
PROJECT NARRATIVE Appointment no-show remains a stubborn feature of psychiatric care and reducing no-show can improve health outcomes for patients by improving continuity of care and reducing waste for health systems. Using electronic health records (EHR) from a cohort of at least 23,420 patients with depression with 765,512 scheduled psychiatric appointments in Johns Hopkins Medicine between 2016 - 2024, this proposal will 1) use instrumental variable analysis to assess the effect of out-of-pocket costs on appointment no-show, 2) use contemporary matching techniques to estimate the causal effect of clinical operations features (such as telehealth and appointment reminders) on no-show and examine if the effect differs across groups with different financial assets (such as insurance and area credit scores), and 3) use modern prediction models to examine which financial and non-financial factors predict no-show. Findings will inform priorities for interventions to reduce psychiatric appointment no-show and improve population mental health.